Organization and Development of Functional Representations in Visual Cortex

Project Summary/Abstract
Establishing how features of the visual world are represented in the activity of cortical circuits, and how these
representations are constructed during development, remain fundamental challenges for visual neuroscience
and are central to understanding the neural basis of visual perception. A critical function of circuits in primary
visual cortex is the integration of the inputs from the two eyes to create a single binocularly aligned representation
of stimulus features such as the orientation of edges. This alignment is evident in the responses of individual
neurons in visual cortex such that visual stimuli presented to either eye yield highly similar responses, giving rise
to our coherent binocular perception of the world which, when disrupted, can lead to a host of symptoms that
together are called binocular vision dysfunction. Research from this lab is focused on understanding the
developmental mechanisms responsible for the binocularly aligned representation of orientation. This work
demonstrates that binocularly aligned responses are not present at the onset of visual experience, emerge after
a week of visual experience, and do not emerge in the absence of visual experience. In recent studies, we have
determined the functional properties of the synaptic inputs to individual cortical neurons and how these inputs
change with experience – leading us to a new hypothesis for the process of binocular alignment. Instead of the
classic model of simple convergence of monocular input streams, we think that the highly aligned binocular
responses of neurons in layer 2/3 (L2/3) of the visual cortex emerge from experience-driven changes in the
functional coherence of monocular and binocular inputs to these neurons from two different sources:
feedforward synaptic inputs from layer 4 (L4) and inputs from other L2/3 neurons that are part of a highly
interconnected recurrent network. The goal here is to test this hypothesis by determining, for the first time, the
distinct functional organization of feedforward and recurrent synaptic inputs to individual L2/3 neurons in
experienced animals (Aim 1), comparing this with the organization in the visually naïve state and testing the role
of visual experience in these changes (Aim 2), and evaluating the contribution of concurrent changes in the
responses of L4 neurons to this process (Aim 3). Together, these experiments should provide a new
understanding of the changes in the functional properties and the synaptic organization of feedforward and
recurrent circuits that contribute to the rapid experience-driven emergence of the binocularly aligned
representation of oriented stimuli in primary visual cortex.

Public health relevance
Project Narrative Despite years of study, we still do not understand the neural circuits responsible for bringing together the information from the two eyes to create a single coherent cortical representation of stimulus features. This project will elucidate how binocular integration is achieved in single cortical cells by integrating inputs from different sources, and the underlying developmental mechanisms that guide this integration process. The resulting insights are critical for addressing disruptions of coherent visual perception that together are called binocular vision dysfunction as well as other developmental defects of cortical circuits that contribute to neurological and psychiatric disorders.